Alcohol Use Phenotypes and Posttraumatic Stress Disorder: Investigating Shared Genetic, Behavioral, and Psychophysiological Risk Factors

Project Summary
Traumatic events are common. Posttraumatic Stress Disorder (PTSD) is one of the most common
disorders resulting from trauma, tending to co-occur with increased alcohol consumption (i.e., alcohol quantity
x frequency [AQF]) and AUD. Much of this research on the comorbidity of PTSD and alcohol phenotypes has
focused on PTSD-AUD. As increased consumption of alcohol is associated with AUD, research is needed to
determine whether the same etiologic processes underlying PTSD-AUD comorbidity are those underlying
PTSD and AQF. Although the pathways by which shared risk for these phenotypes unfolds is unclear,
longitudinal and experimental research suggests effects of distress tolerance (DT), the perceived ability to
withstand negative emotional states, and anxiety sensitivity (AS), cognitive appraisal of anxiety symptoms as
having harmful physical, mental, or social consequences, on PTSD and alcohol phenotypes. Additionally,
genetic influences on PTSD and AQF/AUD may underlie risk for DT and AS. Thus, the goals of this K01
application are threefold: First, the proposed study will use large-scale molecular data and employ cutting-edge
methods to investigate cross phenotype prediction between PTSD-AQF, and PTSD-AUD, and direction of
effect between PTSD and AQF/AUD. Second, this study proposes to investigate the associations between DT
and AS, and risk for PTSD, AUD, and comorbid PTSD-AUD. Finally, via an Exploratory Aim, it will examine
whether genetic risk for AQF, AUD, and PTSD are associated with DT and AS, and if socioeconomic status
and social support moderate these effects.
To achieve these aims, the candidate will be assisted by her mentorship team in the completion of a
comprehensive training plan that maps onto these three goals. Specifically, this K01 application will allow the
candidate to receive training in cutting edge genetic methods (training goal 1), laboratory-based paradigms and
psychophysiological data (training goal 2), the psychiatric and social epidemiology of stress-related
phenotypes (training goal 3), and professional development (training goal 4). With the help of the
multidisciplinary mentorship team, this K01 award will allow the candidate to integrate large-scale genetic
association findings with laboratory-based self-report, behavioral, and psychophysiological measures, to
predict risk for PTSD-AQF/AUD co-occurrence for those of varying SES levels and varying social support. The
proposed study represents an important step forward in clarifying risk factors and mechanisms of this costly
co-occurrence. The environment where the candidate will be trained is ideal for the candidate's long-term goal
of understanding the etiology of co-occurring PTSD and alcohol phenotypes to improve prevention/intervention
programs. This goal is in line with key NIAAA's research priorities, involving identifying mechanisms underlying
AUD and co-occurring mental health problems while integrating genomic and non-genomic factors.

Public health relevance
Project Narrative Alcohol consumption (alcohol quantity x frequency/AQF), Alcohol Use Disorders (AUDs) and posttraumatic stress disorder (PTSD) often co-occur, and there is emerging evidence that shared genetic risk may partially account for the high rates of this co-occurrence. This project seeks to clarify the shared molecular genetic underpinnings of the PTSD-AQF/AUD co-occurrence, while testing two key laboratory-based phenotypes (i.e., distress tolerance and anxiety sensitivity) as potential predictors, and socioeconomic status and social support as moderators of genetic effects. This K01 award will provide the candidate with the necessary training to become an independent, federally-funded investigator in the intersection of traumatic stress-related outcomes, laboratory-based paradigms, and psychiatric and statistical genetics.